Epigenetic Influence of Diet on Bladder Physiology

PROJECT SUMMARY
The high incidence and prevalence of Lower Urinary Tract Dysfunction (LUTD), a common
factor in many bladder disorders in African populations (about 66%, 20% and 6% of the male population
show mild, moderate and severe symptoms respectively), has been related to environmental and
lifestyle factors such as diet. We have previously reported in both normal and diseased bladders, that
diet alters bladder morphology, specifically cell hyperplasia and hypertrophy, causing changes in
function and influencing key calcium-signalling mechanisms responsible for detrusor contractility.
Understanding of the mechanisms responsible for LUTD and other bladder disorders is still very limited;
epigenetics may play a role. Thus, the long-term goal is to determine the epigenetic effects of diet on
bladder physiology and pathophysiology, while also attaining the level of training and expertise required
for me to become an independent researcher. The overall objectives in this application are to (i)
characterize the influence of diet on specific histone modifications and gene expression changes in the
bladder and (ii) relate any observed alterations in histones and gene expression to phenotypic and
functional changes in the bladder. The central hypothesis is that epigenetic modifications contribute to
the molecular changes underlying alterations in bladder morphology and function with different diets.
The rationale for this project is that identification of the epigenetic effects of diet in the bladder will
provide a foundation, and supportive preliminary data, for subsequent studies on the roles played by
diet in the normal bladder and in bladder dysfunction. Diet, being a modifiable factor with great public
health impact, could provide an insight into the mechanisms by which LUTD occur. This project also
offers me the opportunity to establish my independence as an epigeneticist. The central hypothesis will
be tested by pursuing three specific aims: 1) Identify changes in bladder morphology and function after
consumption of different diets (high fat, high carbohydrate, and high protein diets); 2) Identify bladder
transcriptome changes after dietary treatment using RNAseq; and 3) Identify effects of the diets on
histone acyl marks for proliferative status (H3S10P, H3S28P), transcriptional activation (H3K9Ac,
H3K27Ac) and DNA replication (H4K5Ac, H4K12Ac) in the bladder of rats from each dietary group after
feeding. Under the first aim, excised whole rat bladder tissue will be used to identify changes in bladder
weight, detrusor contractility, and bladder histology (haematoxylin and Eosin stain, and
immunohistochemistry) to determine morphological and functional changes as a result of each diet. For
the second aim, RNA sequencing will be done to identify global changes in transcriptome abundance
in each dietary group. To achieve the third aim, protein separation techniques (SDS-PAGE) and
western immunoblotting will be employed to identify changes in specific histone targets. The proposed
research is innovative, because it focuses on a new direction for research into bladder physiology and
pathophysiology, investigating diet, a common modifiable public health factor in all patients and a
common denominator in the aetiologies of several non-communicable diseases, and how its effects on
epigenetic modifications, influencing transcription and expression of genes could result in LUTD. The
proposed research is significant because it is expected to advance scientific knowledge on the
mechanisms of bladder function, and provide an initial standpoint and data upon which subsequent
studies on the epigenetic roles played by diet in bladder dysfunction will build. It will also provide data
to support new intervention strategies for the management of LUTD and other non-communicable
dieases.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it investigates a new and alternative strategy to understanding the potential mechanistic link between diet and bladder dysfunction through epigenetic modifications in LUTD, an understudied disorder with high prevalence in African countries, opening up new directions for possible public health impact and other management strategies. Thus, the proposed research is relevant to the NIH’s mission to “foster fundamental creative discoveries, innovative research strategies, and their applications as a basis for ultimately protecting and improving health”.